Integrated Molecular and Cellular Drivers of Alveologenesis

PROJECT SUMMARY
Neonates born during the saccular stage of lung development (23-32 wks gestation) are at highest risk for
bronchopulmonary dysplasia (BPD), a leading preterm birth complication. The mechanisms underlying this
vulnerability are poorly defined, a knowledge gap we consider foundational to the lack of curative BPD
therapies. To understand the irreversibility of arrested alveologenesis in BPD, we require a refined,
mechanistic understanding of the normal saccular to alveolar transition. Our preliminary data from 4-
dimensional live imaging and single-cell transcriptomics support a new model of alveologenesis in which
myofibroblast ring structures support the extrusion of AT2s (alveolar type 2 cells) followed by their
differentiation into AT1s (alveolar type 1 cells). According to our model, mature AT1s produce ECM proteins
and other factors that recruit specialized endothelial cells to become the alveolar capillary bed. Sequential,
spatiotemporally restricted signaling pathways, including Wnt and BMP, coordinate cell movement,
proliferation, and architecture. We have developed a neonatal injury model with a phenotype of impaired
alveologenesis that is relevant to human BPD by exposing neonatal mice to hyperoxia and inflammation during
the saccular stage. Our preliminary data from this model associate overexpression of Wnt5A/Wnt11 with
impaired alveologenesis. Post-injury deficits include decreased BMP production and activity in alveolar
epithelial cells and impaired AT2 to AT1 cell differentiation and decreased expression of extracellular matrix
(ECM) components by AT1 cells. Based on preliminary and published data, we hypothesize that
alveologenesis involves formation of a ring of myofibroblasts that express Wnt5a and Wnt 11 to drive AT2
proliferation and promote extrusion through the ring. Subsequent epithelial BMP production down-regulates
Wnt, promoting AT2 to AT1 differentiation and generation of an extracellular scaffold for capillary assembly.
Injury dysregulates Wnt and Bmp signaling, perturbing the precise spatiotemporal patterning during this critical
timeframe and resulting in arrested alveologenesis and long-term functional deficits. We will test this
hypothesis in the following specific aims: 1) Define the role of myofibroblast Wnt expression in regulating
AT2 proliferation and alveolar development; 2) Characterize mechanisms by which BMP signaling
regulates AT2-to-AT1 cell differentiation; 3) Determine the mechanisms whereby nascent AT1 cells
generate a scaffold for the developing alveolus. Successful completion of this proposal is anticipated to
transform our understanding of alveologenesis, identifying new molecular targets to promote post-injury
alveolar restoration and the optimal time windows for deployment of such newly directed therapies.

Public health relevance
PROJECT NARRATIVE As the lung develops, precisely timed interactions between epithelial and mesenchymal cells promote the growth of new alveoli and the differentiation of alveolar type 2 cells into alveolar type 1 cells. Preterm birth during the saccular stage disrupts this process leading to dysregulation of two key signaling pathways – Wnt and BMP – with resulting arrested lung development and permanent deficits in pulmonary function. In this proposal, we will synthesize data from live microscopy, single-cell multiomics, and spatial transcriptomics to define the role of Wnt and BMP signaling in normal alveologenesis and in neonatal lung injury, which will provide foundational data for new approaches to restore normal lung growth after preterm birth.